APPLICATION OF HIGH-PERFORMANCE COMPUTING TO THE RECONSTRUCTION, ANALYSIS, AND

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The field of biology is undergoing a fundamental shift from a data poor field to a data rich field thanks to the advent of numerous new high-throughput technologies for the collection of experimental data: Shotgun sequencing, Pyrosequencing, Microarrays, ChIP-chip, Biolog phenotyping arrays, microfluidic devices, and flow cytometry. Today simulation is struggling to keep pace with data collection in many areas, and nowhere is this more evident than in genome-sequencing versus genome-scale modeling. While over 800 prokaryotic genomes have been sequenced in the past ten years, only 30 genome-scale metabolic models have been published, and the pace of genome-sequencing continues to increase threatening to extend this already massive gap. Today, the paradigm of the genome-scale metabolic modeling community is that it requires a year or more of manual effort to produce a new model of a microorganism. However, technologies have emerged in recent years that make it possible to automate or expedite various steps of the genome-scale reconstruction process, and we have recently tied these technologies together into an automated genome-scale model reconstruction pipeline. While this pipeline makes it possible to construct a single model in one to five days, extensive computation is required in this reconstruction process. We are proposing to use the computational resources in the TerraGrid to apply this reconstruction process to build new genome-scale metabolic models for every prokaryote with a completely sequenced genome. We then plan to use these models in a number of high-impact scientific studies including: (1) simulating the knockout of every metabolic gene to study the robustness of the metabolic networks of these organisms and identify new potential targets for future antibacterial drug development, (2) simulating growth of each microorganism in a variety of chemical conditions to identify the environments in which various communities of microorganisms are capable of surviving, (3) predicting the minimal defined media conditions that are required in order to culture each modeled organism, and (4) simulating the engineering of each modeled organism to produce organic compounds of industrial value from a variety of renewable raw materials. While these studies produce very different results and appeal to fundamentally different application areas, they all can be accomplished by applying the Flux Balance Analysis method to the genome-scale metabolic models we will be constructing. The primary algorithm we will be using in the proposed reconstruction and analysis of genome-scale models is flux balance analysis. The most significant computation involved in this algorithm is the solving of a linear or mixed integer linear optimization problem. Fortunately, numerous open source software is available for solving linear and mixed integer linear optimization problems. We will be applying the GLPK, SCIP, and BCP solvers along with our own custom built MPI-ready FBA software to perform all of the proposed reconstruction and analysis calculations. In total, we expect that 104 distinct mixed integer linear optimization problems and 1012 distinct linear optimization problems will need to be solved in the first year of this project, requiring a total of 1.5 million CPU hours. In the two following years, we anticipate an equal number of simulations will be required due to the release of additional sequenced organism and the update of the annotations in the existing organisms.